Developing IL-10 encapsulated exosomes as novel therapeutics for spontaneous preterm birth

ABSTRACT
Present therapeutic agents are designed to inhibit the myometrial contractions or cervical ripening to delay
delivery in the risk of spontaneous preterm birth (PTB). These approaches have limited success in reducing
the overall rate of PTB, which his ~11% in the USA. A novel drug delivery system needs to be designed to
improve pregnancy outcomes. Successful pregnancy is determined by regulatory mechanisms at the F-M,
ensuring that both innate and adaptive immune cells aptly support fetoplacental development by balancing
inflammation while remodeling uterine tissues. Immune dysregulation, primarily mediated by a fetal
inflammatory response to pregnancy-associated risk factors (eg, infections), leads to PTB. The inability of
drugs to cross feto-maternal interface barriers to treat both the mother and her fetus, as well as lack of proper
ways of testing drug transport, metabolic changes, teratogenicity, and cytotoxicity, has hindered PTB drug
development. Using, the naturally occurring anti-inflammatory cytokine interleukin (IL)-10, enclosed in
exosomes (extracellular vesicles, 40–160 nm) engineered by electroporation (eIL-10), IL-10 crossed the
placental barrier, delayed PTB induced by LPS, and reduced fetal inflammatory response compared to LPS
alone. However, the method of electroporation will alter the tropism of exosomes, and the production of
recombinant IL-10 loaded exosomes is very expensive. To overcome these electroporation limitations, we
developed an alternate approach to produce large quantities of IL-10 enriched exosomes by incorporating IL-
10 plasmid into mouse macrophages (RAW 264.7 cells) and stimulating them with dexamethasone (Dex). Dex
induces IL-10 production and will be packaged in large quantities in exosomes (eIL-10). This approach has
overcome the limitation of electroporation and increased the efficiency of IL-10 packaging in exosomes during
biogenesis. Thus, the approach minimizes alterations of exosome proteins, and the production of eIL-10 will be
cost-effective. We will test the hypothesis that eIL-10 will reduce the incidence of ascending infection (E. coli)
induced PTB mouse model. We propose the following aims to test our hypothesis.
1) To characterize eIL-10 and determine its functional activity in in vitro studies,
2) To determine efficacy and biodistribution of exosomal IL-10 (eIL-10) in in vivo studies.
Our innovative approach will prolong pregnancy and can translate into a critically needed specific interventional
strategy to decrease infection/inflammation associated with PTB
and thereby improve pregnancy outcomes.

Public health relevance
PROJECT NARRATIVE Preterm birth (PTB) is a birth before 37 weeks of gestation period. Current therapeutic strategies either doesn't cross the fetal-maternal interface or causes toxicity to fetal tissues. We developed a safe, stable, and inert nanoparticle (exosomes) to delay preterm birth with natural anti-inflammatory cytokine interleukin (IL)-10.